Chemical Probes of Lectin Function

Project Summary/Abstract Section
The glycan coat is an evolutionarily conserved feature of all cells that depends on cell identity
and state. Human lectins read this glycan coat to influence immunity and tolerance. For most
human lectins, we lack information on what cell types they bind. More profound knowledge of
lectin action can yield novel biomarkers and tailored therapies for diseases ranging from
inflammatory bowel disease to cancer. The proposed aims focus on developing new tools to
address the current knowledge gaps. The goal of Aim 1 is to create a general strategy to assess
the microbe binding selectivity of soluble human lectins. We anticipate this Aim will afford tools
that provide insight into how lectins influence human microbial communities. We are especially
interested in what host species lectins have evolved to recognize and how their recognition
affects their microbial targets. In Aim 2, we shall devise a capture agent that can be used to
assess the glycan targets of lectins. Our objective is to fill a gap in the tools available to identify
physiological protein-glycan interaction partners. Aim 3 focuses on studying and engineering a
lectin that can bind and kill bacteria. We aim to understand how this lectin exerts its
antimicrobial activity and engineer new variant proteins that can target and eliminate
pathogens.
Significance
This application aims to develop new strategies to identify what cells our carbohydrate-binding
proteins prefer and why. We anticipate that this knowledge will yield new insights into the roles
of these proteins in a wide range of areas relevant to human health.

Public health relevance
Project Narrative All cells have a carbohydrate coat that varies with cell type, and this coat is read by proteins of our immune system called lectins. While we know that human lectins can detect foreign, damaged, cancerous, or beneficial cells, we do not fully understand what kinds of cells human lectins bind and the consequences of that binding. This project is focused on providing that understanding because it can lead to new strategies to detect and treat diseases that encompass inflammation, cancer, and infectious disease.